BLRD Research Career Scientist Award Application

Cancer cells reprogram their metabolism to fuel anabolic processes required for their proliferation and
survival. One way by which cancer cells reprogram metabolism is by hijacking the evolutionarily conserved
metabolic function of the PI3K/Akt/mTORC1 signaling pathway. Another way is by markedly elevating the
expression of the hexokinase isoform, HK2, which catalyzes the first committed step in glucose
metabolism. The long-term goal of this grant application is to overcome challenges in targeting cancer
metabolism and Akt for cancer therapy. Although cancer cells can be selectively detected because of their
high glucose metabolism (FDG-PET scan), exploiting this property for selective targeting is challenging
because interference with glucose metabolism could have adverse consequences. We overcame this
roadblock by showing that hexokinase 2, which catalyzes the first committed step in glycolysis, and is
selectively expressed in cancer cells, can be systemically deleted in mice without any adverse
consequences. The proposal is based on findings made in my laboratory at the cellular and organismal
levels, and address the following paradigm shifts: (i) Germ-line deletion of hexokinase 2, which is markedly
elevated in cancer cells, is embryonic lethal. However, we found that its systemic deletion in adult mice is
well tolerated, and therapeutic in several mouse models of cancer. We identified a role of hexokinase 2
(HK2) in EMT and metastasis through a novel mechanism which is independent of its kinase activity.
Recently we showed that Hk2 is required for liver fibrosis through mediating histone lactylation. We will
continue investigating this observation to find therapeutic approaches to treat liver fibrosis and
consequently MASH-induced HCC. (ii) The inhibition of AMPK is considered pro-tumorigenic.
Paradoxically, we found that AMPK activation is required for cell survival during solid tumor formation and
metastasis. The role of AMPK in metastasis is dependent, at least in part, on the induction of the fatty acids
translocator CD36 expression. We will delineate the role of AMPK during metastasis in human cells and
mouse models of breast and prostate cancer. We anticipate that the proposed studies will uncover new
mechanisms of tumorigenesis associated with cancer metabolism, and yield strategies that exploit cancer
metabolism for cancer therapy.

Public health relevance
Studies suggest that veterans are at a higher risk of developing breast cancer than the rest of the population. The metastatic spread of breast cancer cells from the primary tumor to surrounding tissues and to distant organs remains the primary cause of breast cancer morbidity and mortality. Despite the deleterious consequences of metastasis, a robust understanding of how the process is initiated, the metabolic signatures and signaling components involved in regulating the same are still nebulous. During invasion, cancer cells show altered and decreased cell–matrix interaction and this interaction is further reduced in the circulation. An inevitable outcome of matrix detachment is reactive oxygen species (ROS) accumulation and enhanced anti-oxidant defenses permit cancer cells to survive as circulating tumor cells in vivo. Thus, understanding the mechanism by which metastatic cells combat ROS could lead to therapeutic strategies that eradicate breast cancer metastatic cells.